Understanding the Conceptual Priority Map Guiding Naturalistic Visual Attention for Autistic Individuals

Project Summary
Visual attention differences are a promising diagnostic marker for autism spectrum conditions (ASC). Yet,
despite mounting evidence for group-level differences in visual attention, particularly for visual attention directed
toward socially relevant information (i.e., “social gaze”) between autistic and non-autistic individuals, the source
of gaze differences in autism remains unclear. Prominent theories of social gaze differences focus heavily on a
particular category of visual stimuli, namely: faces. What these theories leave unanswered is whether reduced
social attention is, in fact, best explained by atypical attention to a specific stimulus class or whether it reflects
an underlying reduction in attention to distributed (face and non-face) sources of important social information in
complex environments. In other words, social information may not be limited to a single visual category, and it
may not be categorical in nature at all. Yet, by focusing on object categories, eyetracking analyses have failed
to capture the richness and complexity of real-world environments in which visual attention supports an
individual’s behavior. In order to leverage visual attention as a clinically actionable tool, a critical knowledge gap
must be addressed: are social gaze differences in autism driven by information at the level of visual categories,
or instead, by higher-order conceptual information beyond the visual domain?
The objective of this project is to examine the impact of both categorical and conceptual levels of
information on individual and autistic group differences in visual attention. The central hypothesis is that visual
attention differences in autism stem from conceptual-level, rather than categorical-level, differences in mental
processing. To test this hypothesis, I have developed a novel approach that uses tools from computer vision
(computational neural networks; CNNs) and natural language processing (NLP) to characterize individually
unique patterns of visual attention. First, Specific Aim 1a will test whether gaze patterns reflect high-dimensional
conceptual priorities that are unique to individual participants (N = 62 non-autistic adults). Specific Aim 1b will
test whether conceptual priorities reliably guide autistic individuals’ (N = 28) gaze and can be used to classify
individuals by diagnostic status (autistic vs. non-autistic). Specific Aim 2, the postdoctoral research direction,
will extend the focus of my dissertation research, on conceptual priorities that drive visual attention, to conceptual
priorities outside the visual domain, such as language. These aims have been articulated as part of a structured
training plan designed to facilitate the transition to a postdoctoral position and independent research career. This
training plan emphasizes skill development in multivariate statistical analysis, experimental design, and scientific
communication. This training plan is sponsored by Dr. Caroline Robertson, whose expertise in autism, visual
processing, and novel experimental techniques (e.g., virtual reality) is ideally complemented by the technical and
computational strengths in the Psychological and Brain Sciences Department at Dartmouth.

Public health relevance
Project Narrative Visual attention – “gaze” – is a promising biomarker for autism: it can be passively measured from non- and pre-verbal individuals, thus facilitating clinical diagnosis before hallmark behavioral traits (e.g., language delay) have fully emerged in development. A key step in leveraging gaze as a clinical tool will be to understand the mental processes underlying autistic group differences in visual attention. The project proposed here directly relates to the NIH BRAIN priority to understand foundational mental processes using new theoretical and data analysis tools.